Linking Histone Modifications, HSF-1 activity and Lifespan

One of the most fascinating questions in the aging field is: Why do some organisms live longer than others?
That lifespan variations are not solely based on the genetic makeup or the environment becomes clear when
one studies isogenic organisms, such as Caenorhabditis elegans. Even when carefully age-synchronized and
cultivated under uniform environmental conditions, the lifespan of individuals within a population of C. elegans
varies several-fold. What causes this lifespan variation and when is the clock set? Our previous work
demonstrated that individuals of a synchronized C. elegans population show high inter-individual differences in
their levels of endogenous reactive oxygen species (ROS) during early development. Sorting of larval worms
according to their endogenous redox states (i.e., oxidized vs. reduced) followed by longitudinal physiological
and cell-biological assays revealed that larval worms that are more oxidized have significantly increased stress
resistance, a more reduced redox state during adulthood and a longer lifespan. We found that this increase in
stress resistance and lifespan is due to the ROS-dependent transient inactivation of Set2, a conserved
member of the COMPASS complex, the complex which is responsible for the trimethylation of H3K4 (i.e.,
H3K4me3) in eukaryotes. To our knowledge, these studies not only provide the first demonstration of a redox-
regulated histone methylation event in biology, but are the first to give mechanistic insights into how early life
events can increase longevity. We will now investigate the mechanisms by which a decrease in H3K4me3
levels during development leads to increased stress resistance and extended lifespan. Our proposed studies
are guided by preliminary results, which demonstrate a hitherto unknown link between the global reduction in
H3K4me3 marks, and the increase in the levels and activity of the heat shock factor HSF1, one of the most
conserved longevity factors known. We will exploit genetic tools in C. elegans to directly monitor the effects of
H3K4me3 depletion on HSF1 synthesis, stability and turnover, and deplete H3K4me3 levels at defined time
points and in specific tissues to reveal when, how and in what tissues the individuality in lifespan arises. To
determine where developmental ROS variations come from, we will follow up on exciting preliminary data
suggesting that the redox states in developing C. elegans larvae (and hence their lifespan) are inversely
related to the age and redox state of the mother. These studies are likely to shed new mechanistic insights
into the Lansing Effect, a long recognized but so far mostly descriptive phenomenon that describes the
negative relationship between the maternal age and the lifespan of the offspring. The results of these studies
will provide fundamentally new insights into the underlying mechanisms that lead to early life redox variations,
and the subsequent events that delay aging.

Public health relevance
When and how is lifespan determined, and why do some organisms live longer than others? Our previous work identified early life variations in the cellular redox state as lifespan modulators in the aging model organism Caenorhabditis elegans. We will now investigate the underlying mechanisms that lead to early life redox variations, and how they can lead to a longer lifespan.